MONTHLY AEROSOLIZED PENTAMIDINE AND THRICE WEEKLY DAPSONE FOR PCP IN HIV

Prospective, randomized, study of the safety and efficacy of aerosolized pentamidine (AP) and dapsone in the prevention of Pneumocystis carinii pneumonia (PCP) in high-risk HIV infected patients who are intolerant to trimethoprim and/or sulfonamides. To date only aerosolized pentamidine has been approved by the FDA for the prevention of PCP.